Administrative

All projects and cores in the Program Project will be supported by the Administrative Core. Dr. Bers will serve as Administrative Core Leader and will work with the Program Project Executive Committee and the Internal and External Advisory Boards to provide oversight for the coordination and reporting activities of this Core. Ms. Caroline Kappers, Grants Administrator for the Physiology Department, will work directly with Dr. Bers and have responsibility for fiscal management of the budgets and budget reporting. She will serve as liaison for financial aspects of the subcontracts with UCSD and UIC. With the assistance of Ms. Kay Frezek, Physiology Department administrator, the Administrative Core will provide monthly financial status reports to project and core leaders. This core will have the responsibility of organizing regular meetings for project and core leaders and will be responsible for the planning of annual workshops which will include all Program Project research personnel and members of the External Advisory Board. Travel costs for the External advisors to attend these annual meetings at Loyola University Chicago are centralized in this core. The cost of travel for grant personnel to attend two group meetings per year (one in Chicago and one in San Diego) are also centralized in this Administrative Core. This core will also oversee all aspects of visits by consultants and seminar speakers.